Hospital-to-SNF Transitions of Care in Patients with End-Stage Kidney Disease

PROJECT SUMMARY/ABSTRACT
Over 550,000 Americans have end-stage kidney disease (ESKD) requiring dialysis and patients with
ESKD have very high rates of hospitalization and skilled nursing facility (SNF) admission. Transitions of care
between acute and post-acute settings can be suboptimal because patients with ESKD have a high degree of
medical complexity. Suboptimal hospital-to-SNF care transitions likely contribute to the very high hospital
readmission rates (33%) among patients with ESKD. Hospitalizations, readmissions, and SNF stays for patients
with ESKD account for >$10 billion in Medicare spending. Although SNF admissions are common and costly
among patients with ESKD, very little is known about hospital-to-SNF care transitions in this population. The
choice of SNF and whether dialysis is available on-site can shape both the continuity and quality of dialysis care.
For example, it is unknown how commonly patients with ESKD receive hemodialysis treatments on-site at the
SNF, off-site at the same dialysis facility they used prior to hospitalization, or off-site at a different dialysis facility
during the SNF stay. It is also unknown how often patients receiving peritoneal dialysis (the dominant form of
home dialysis in the US) are able to continue peritoneal dialysis while admitted to a SNF vs. having to transition
to hemodialysis and whether such transitions are temporary or sustained. Optimizing hospital-to-SNF care
transitions among patients with ESKD is crucial to improve quality of care for this medically complex population.
In Aim 1, we will characterize patterns of hospital-to-SNF care transitions among patients with ESKD using
Medicare claims and identify patient, dialysis facility, SNF, and market characteristics associated with those
patterns. Aim 2 will examine the association of hospital-to-SNF care transitions patterns for patients with ESKD
with established measures of quality of care (e.g., discharge home, 30-day readmissions, 30-day ED visits,
functional improvement, pain, mortality). Our central hypothesis is that there will be significant variation in
continuity and quality of care by patient, dialysis facility, SNF, and market characteristics, and that on-site
hemodialysis and off-site hemodialysis with continuity will be associated with better outcomes, compared to not
having continuity in outpatient dialysis facilities. Aim 3 will elicit the qualitative experiences and perspectives
regarding hospital-to-SNF care transitions of patients with ESKD and their clinicians. In semi-structured
interviews informed by care transitions conceptual frameworks, we will seek to understand ESKD care transition
experiences and identify opportunities for improvement. Findings from this research will generate the first
national data on hospital-to-SNF care transitions among patients with ESKD while building foundational insights
that will inform future interventions to improve care transitions in this population.

Public health relevance
PROJECT NARRATIVE Patients with ESKD have very high rates of hospitalization and short-stay skilled nursing facility (SNF) admission; suboptimal hospital-to-SNF care transitions could lead to hospital readmission and adverse outcomes. This research will characterize patterns of hospital-to-SNF care transitions and their association with quality of care among patients with ESKD. We will also interview patients with ESKD and their clinicians to elicit their experiences and perspectives regarding hospital-to-SNF care transitions and identify opportunities for improvement.